Neuronal mechanisms of human episodic memory

Project Summary
The rapid formation of new memories and the recall of old memories to inform decisions is essential for human
cognition, but the underlying neural mechanisms remain poorly understood. The long-term goal of this research
is a circuit-level understanding of human memory to enable the development of new treatments for the
devastating effects of memory disorders. Our experiments utilize the rare opportunity to record in-vivo from
human single neurons simultaneously in multiple brain areas in patients undergoing treatment for drug resistant
epilepsy. The overall objective is to continue and expand a multi-institutional (Cedars-Sinai/Caltech, Johns
Hopkins, U Toronto, Children's/Harvard, UC Denver, UCSB), integrated, and multi-disciplinary team. Jointly, we
have the expertise and patient volume to test key predictions on the neural substrate of human memory. We will
utilize a combination of (i) in-vivo recordings in awake behaving humans assessing memory strength through
confidence ratings, (ii) focal electrical stimulation to test causality, and (iii) computational analysis and modeling.
We will apply these techniques to investigate three overarching hypotheses on the mechanisms of episodic
memory. First, we will determine the role of persistent neuronal activity in translating working memories into long-
term declarative memories (Aim 1). Second, we will determine how declarative memories are translated into
decisions (Aim 2). Third, we will investigate how event segmentation, temporal binding and reinstatement during
temporally extended experience facilitate episodic memory. The expected outcomes of this work are an
unprecedented characterization of how episodic memories are formed, retrieved and used for decisions, and
how temporally extended experiences are segmented to form distinct but linked episodes. This work is significant
because we move beyond a “parts list” of neurons and brain areas by testing circuit-based hypotheses by
simultaneously recording single-neurons from multiple frontal cortical and subcortical temporal lobe areas in
humans who are forming, declaring and describing their memories. The proposed work is unusually innovative
because we combine single-neuron recordings in multiple areas in behaving humans, develop new methods for
non-invasive localization of implanted electrodes and electrical stimulation and directly test long-standing
theoretical predictions on the role of evidence accumulation in memory retrieval. A second significant innovation
is our team, which combines the patient volume and expertise of several major centers to maximally utilize the
rare neurosurgical opportunities available to directly study the human nervous system. This innovative approach
permits us to investigate circuit-level mechanisms of human memory that cannot be studied non-invasively in
humans nor in animal models. This integrated multi-disciplinary combination of human in-vivo single-neuron
physiology, behavior, and modeling will contribute significantly to our understanding of the circuits and patterns
of neural activity that give rise to human memory, which is a central goal of human neuroscience in general and
the BRAIN initiative in particular.

Public health relevance
Project Narrative The rapid formation of new memories and the recall of old memories to inform decisions is essential for human cognition, but the underlying neural mechanisms remain poorly understood. The objective of this application is to assemble a multi-disciplinary and multi-site team with the expertise and patient volume to test key predictions on the neural substrate of human memory that can only be evaluated by observing and studying neurons in-vivo in humans enabled by rare neurosurgical opportunities. This innovative approach permits us to investigate circuit-level mechanisms of human memory that cannot be studied non-invasively in humans nor in animal models due to their unclear relevance to human memory and its diseases.